Modeling the Coupled Dynamics of COVID-19 Transmission and Protective Behaviors

Project Summary/Abstract
A growing number of COVID-19 transmission models have been developed to help forecast the on-going epi-
demic and compare outcomes of different non-pharmaceutical interventions (NPIs) in terms of cases, deaths,
and medical supply needs. Most of these models do not include adaptive behavioral effects describing how risk
perceptions and fatigue inﬂuence engagement with social distancing and transmission reduction. Decisions on
mask-wearing, levels of social contact, and vaccination will deﬁne whether the epidemic is controlled or enters
annual circulation. We propose the development of population-based (PBM) and agent-based (ABM) transmis-
sion models to study the interplay between individual behavior and transmission dynamics, while considering the
many uncertainties which still surround the virus, such as seasonal effects and the loss of immunity. Addition-
ally, our models will be used to study how COVID-19 and seasonal inﬂuenza and respective behaviors interact,
exacerbate outcomes, and potentially overwhelm the health care system. These models will build upon our prior
research. Since Fall 2016 we have conducted regular longitudinal surveys investigating attitudes towards, risk
perceptions of, and propensity to vaccinate for seasonal inﬂuenza. The ABM models constructed from these data
account for adaption and memory of past experiences, peer effects, and population heterogeneity. Using machine
learning methods, we have augmented a synthetic network representative of a small US city with this behavioral
data. We have continued to conduct modiﬁed versions of these surveys to track how these beliefs translate to
COVID-19. In parallel, we have developed a compartmental population-based model of COVID-19, which models
transmission and the effects of NPI intensity and timing on both health and economic outcomes. We propose to
extend our current compartmental PBM and build a new individual-level ABM, informed by longitudinal surveys.
We will conduct a four-year longitudinal panel survey to construct an empirical behavioral model for decisions
to socially distance, engage in transmission reduction measures (such as mask-wearing), and vaccinate. This
information will be combined with our existing synthetic network data-set to enable us to build an individual level
ABM of the spread of COVID-19 in a representative US city, integrated with our inﬂuenza ABM. This model will
capture both how individual behaviors impact macro-level disease transmission and how inﬂuenza and COVID-19
could interact. Insights and data from our individual-level model will be used to inform and parameterize adaptive
behavior within our compartment-level model, allowing for policy comparisons across a range of US states. In
addition, we will consider which policies are robust to key behavioral and technological uncertainties, such as the
extent of behavior change in response to perceived risk and the timing and effectiveness of vaccines. Finally,
we will develop web-based interactive tools that allow for the exploration and comparison of different policies in a
variety of potential futures.

Public health relevance
Project Narrative The trajectory of the COVID-19 epidemic is shaped by individual behavior. We propose the development of new transmission models of COVID-19 and seasonal inﬂuenza that study the interplay between individual behavior and transmission dynamics, while considering important uncertainties, such as seasonal effects and the loss of immunity. Building on our prior work on vaccination behaviors for inﬂuenza and the transmission of COVID-19, these models will be informed by tailored longitudinal surveys, observed behavior, and case data from the ongoing pandemic, and we will develop tools that run our models and allow users to identify the effects of behavioral factors on policy effectiveness, evaluate the potential impact of vaccine availability, and identify strategies that are robust to a wide range of uncertainties.